Cancer Center Support Grant

ABSTRACT
Memorial Sloan Kettering Cancer Center (MSK) is a free-standing NCI-designated Comprehensive
Cancer Center dedicated to improving the standards of cancer treatment, prevention and control. MSK’s
research programs are grouped into three categories: Basic Research (Regulation of Cell Behavior,
Developmental and Stem Cell Biology, Genomic Integrity, and Structural and Chemical Biology); Bridge
Research (Cancer Biology and Experimental Pathology, Experimental Therapeutics, Immunology and
Transplantation, and Imaging and Radiation Sciences); and Patient-Oriented Research (Clinical Research and
Population Science Research). The programs are designed to optimize the use of a large patient population
and an extensive, multi-disciplinary staff of clinical and laboratory-based investigators. MSK seeks to
encourage the application of scientific discoveries in a way that advances the prevention, detection, diagnosis,
and treatment of the many forms of cancer that are relevant to the population in our catchment area. Scientific
work in the 10 research programs depends on services provided by 26 core facilities. We are requesting
funding from the Cancer Center Support Grant (CCSG) for 20 of these core facilities.
Over the next five years, MSK will continue to enhance its clinical and research facilities and its research
and training programs in emerging research areas. Support is requested to provide developmental funding for
the support of newly recruited investigators in computational biology, to support cross-disciplinary pilot projects
in population science research, and to support the core facilities.

Public health relevance
PROJECT NARRATIVE Memorial Sloan Kettering Cancer Center (MSK) is a free-standing institution dedicated to the control of cancer through inpatient and outpatient care, clinical and research training programs, and a broad spectrum of research activities. Through these activities, MSK seeks to reduce the burden of cancer throughout our catchment area and the nation.